SERIAL SYSTOLIC AND DIASTOLIC LV FUNCTION IN DOXORUBICIN CARDIOMYOPATHY

Serial studies on doxorubicin induced cardiomyopathy were studied in relation to systolic function as well as diastolic filling characteristics during rest and exercise.